Mentored Training in Molecular Epidemiology of Chronic Kidney Disease in Diverse Populations

ABSTRACT
Chronic kidney disease affects one in seven U.S. adults and is a leading cause of death and disability. Chronic
kidney disease has a substantial impact on U.S. diverse populations, including Blacks, Hispanics/Latinos and
American Indians. Research on the epidemiology and molecular risk factors contributing to chronic kidney
disease in diverse populations is much needed to guide public health prevention and interventions, and to
develop therapeutic tools for clinicians to effectively treat the disease. This K26 application will support
protected time for Nora Franceschini, MD MPH, to mentor junior investigators from underrepresented groups in
science on molecular epidemiology research of chronic kidney disease in diverse populations. Dr. Franceschini
is a nephrologist and an epidemiologist with a 20-year experience conducting multidisciplinary studies in
chronic kidney disease and mentoring graduate students and early-stage investigators, including those from
underrepresented groups. Dr. Franceschini has developed a strong National Institutes of Health supported
research program on chronic kidney disease at the University of North Carolina focused on diverse
populations. This research program offers multiple opportunities for trainees to learn rigorous research skills in
state-of-art approaches for research in the epidemiology, molecular epidemiology and biomarkers of chronic
kidney disease. Proposed activities and enhanced mentoring skills support the goals to increase high-quality
mentoring for the next generation of scientists (including URGs) in chronic kidney disease research within her
research program.

Public health relevance
PROJECT NARRATIVE Nora Franceschini, MD MPH, is a nephrologist and an epidemiologist with a 20-year experience conducting multidisciplinary studies in chronic kidney disease and mentoring graduate students and early-stage investigators, including those from underrepresented groups. The goal of this award is to increase mentoring of junior investigators from underrepresented groups in science on molecular epidemiology research of chronic kidney disease in diverse populations, through activities based on her research program and the University of North Carolina graduate school.